Defining the neurotoxic and neurodevelopmental health risks of per- and polyfluoroalkyl substances

PROJECT SUMMARY
Per- and polyfluoroalkyl substances (PFAS) are a diverse class of used chemicals that have become ubiquitous
in the environment, contaminating our food and water supplies. A recent survey showed 97% of Americans have
detectable PFAS levels in their blood, resulting from unintentional exposures and bioaccumulation of PFAS.
Exposure to PFAS has been linked to neurotoxicity and negative neurodevelopmental effects, among other major
health risks to humans. Studies examining the connections of PFAS with autism spectrum disorder (ASD),
attention-deficit/hyperactivity disorders (ADHD), and other behavioral and cognitive disturbances in children
showed conflicting results. The specific effects of PFAS exposure on neurons and health risks associated with
such exposure are poorly defined. Our preliminary analyses suggest the cellular uptake of PFAS might be
mediated by a fatty acid transporter, CD36, and PFAS may have different interactions with transporter proteins
based on their chemical structure. Further, we showed in a zebrafish model that bioaccumulation of
perfluorooctane sulfonic acid, a legacy PFAS, impacts learning capabilities. The long-term objective of this study
is to characterize the mechanisms through which PFAS affect brain development and function. We hypothesize
PFAS uptake and bioaccumulation is facilitated by transporter proteins and exposure to PFAS during
embryogenesis has lasting impacts and contributes to the etiology of neurodevelopmental disorders. The
specific aims of this study are to: (1) define the chemical interactions that mediate neuronal uptake and
accumulation of PFAS; (2) elucidate the neurotoxic effects of PFAS and their mixtures in vitro and in vivo;
and (3) assess impacts of PFAS on neurodevelopment, and on the development of complex behaviors in
vivo using gene expression analysis and phenotypic assays. Zebrafish will be used as a model species to
define the effect of PFAS on neurodevelopment and associated behaviors. Our workflow, combining molecular
dynamics simulations, direct binding assays, and cellular and organismal assays, will define the mechanism of
cellular uptake and identify the effects of PFAS exposure on mitochondrial dysfunction, apoptosis, and
neural activity. We will implement a two-tiered exposure study. First, since cellular bioavailability of PFAS
is limited by binding to serum proteins, we will use high concentrations to achieve levels relevant for tissue
bioaccumulation and to establish relative cytotoxicity of different PFAS in vitro and in vivo using phenotypic
endpoint assays. Second, we will utilize environmentally relevant exposure conditions and investigate the
effect of PFAS on gene expression targeting pathways related to neurotoxicity and development. The
results of this study will provide valuable information on PFAS uptake mechanisms, cellular processes, and
cell types impacted by PFAS exposure. Overall, our findings will shed light on the risks associated with specific
PFAS and enable effective interventions for treatment and monitoring of these chemicals.

Public health relevance
PROJECT NARRATIVE Per- and polyfluoroalkyl substances (PFAS) are a group of chemicals that are found in many products and can cause human health problems. Human exposure to PFAS is associated with neurodevelopmental effects, but we currently do not understand why or how. With our work, we will determine the interactions that define the neurotoxic and neurodevelopmental effects of PFAS using various computational and experimental models.